Novel physiomarkers of high-risk labored breathing for advance warning of clinical deterioration

Respiratory failure is common (800,000 yearly intubations), life-threatening (35% mortality rate), and costly
(12% of all hospital costs). Advance warning of respiratory deterioration may trigger timely treatment, but it is
difficult to predict an imminent deterioration despite advanced datasets and analytics. To address this problem,
the proposed project will address a critical gap in contemporary physiological monitoring: the inability to
quantify labored breathing. Breathing patterns (or respiratory kinematics) contain vital prognostic information
that is not captured by conventional monitoring. There has been no way to quantify this information in a clinical
practice setting. As such, this crucial dimension of pathophysiology has neither been rigorously researched nor
has it been integrated into any early warning score. Most insights about the significance of respiratory
kinematics are based on experts’ opinions and on small physiological studies. Little is known about the real-
world distribution of any respiratory kinematic abnormality or its sensitivity, specificity, or predictive value for
respiratory failure. The barriers to large-scale respiratory kinematic measurement were recently
overcome with the development of a simple and scalable new method called ARK (Analysis of Respiratory
Kinematics). ARK uses wearable motion sensors that are easy to apply in any setting. Yet, powered by original
breakthroughs in inertial signal processing, it quantifies respiratory kinematics with high fidelity. Building on this
groundbreaking innovation, the proposed study will pioneer the quantitative documentation of the human
respiratory kinematic profile. The kinematic properties of the mature respiratory system will be recorded in a
large cohort of adults during emergency room visits for respiratory illness. Features of the kinematic signals will
be selected using both clinically-informed and data-driven approaches. In the clinically-informed approach, the
feature selection will be based on an explainable correspondence with motion patterns that are established to
be pathognomonic of high-risk labored breathing. In data-driven feature selection, advanced analytic toolkits
will be used for large-scale, automated feature extraction, and the most informative features will be selected
without regard to visual correlates. High-dimensional kinematic phenotypes will be elucidated by analyzing
variability patterns across multiple features. Finally, this project will achieve the first-ever validation of ARK in a
non-adult population by establishing the safety, feasibility, and validity of ARK monitoring in a cohort of
premature neonates. The main hypothesis is that novel respiratory kinematic physiomarkers (features and
phenotypes) will improve the prediction of severe respiratory failure beyond conventional monitoring. The
proposed work is expected to result in a comprehensive understanding of the diagnostic and prognostic
significance of well-known breathing motion patterns, and the discovery of novel breathing phenotypes. This
work holds the promise for a far-reaching impact, including major leaps in predictive analytics that trigger timely
treatment, reduce ventilator use, unburden ICUs, and save lives.

Public health relevance
Breathing motion patterns (respiratory kinematics) report on a unique and prognostically valuable dimension of pathophysiology, but respiratory monitoring systems are unable to quantify this information in a clinical practice setting. By applying a simple and scalable new method to quantify respiratory kinematics, this project will elucidate the kinematic signatures of respiratory instability more comprehensively than ever before. This work will have a far-reaching impact, including major leaps in predictive analytics that trigger timely treatment, reduce ventilator use, unburden intensive care units (ICUs), and save lives.